Leveraging VA National Data, Expert Consensus, and Veteran Input to Develop and Refine a Pragmatic Trial Protocol Comparing Integrated Interventions to Address Co-Occurring Pain and PTSD in Veterans

Background: Chronic pain and posttraumatic stress disorder (PTSD) are prevalent co-occurring conditions in
Veterans associated with poorer health and functioning. These conditions are challenging to treat, especially
when Veterans are prescribed opioids. Typically, each condition is treated separately, either sequentially,
creating delays, or in parallel with little coordination between providers resulting in each condition negatively
impacting the outcomes of the other. Based on theoretical models, observational evidence, and pilot trials, we
hypothesize that integrated treatments that simultaneously address chronic pain, PTSD, and opioid
dependence may be a feasible and acceptable approach for Veterans with all three conditions.
Significance: National VA/DoD clinical practice guidelines lack information on best practices for managing
comorbid pain, PTSD, and problematic opioid use in VA patients. This represents a key health services gap
leaving large numbers of Veterans at risk for serious adverse outcomes.
Innovation & Impact: With input of subject matter experts (SMEs), Veterans with lived experience, and clinical
data from the VA electronic health record (EHR), we propose to iteratively design a pragmatic implementation-
effectiveness trial comparing two interdisciplinary integrated therapies for the simultaneous treatment of co-
occurring chronic pain and PTSD in Veterans prescribed opioids. This study has the potential for high impact
as the current dominant treatments address each condition sequentially or in parallel and hence risk poor
treatment outcomes and no trials for these co-occurring conditions have included patients prescribed opioids.
High quality pragmatic trials designed as implementation-effectiveness studies conducted by VA clinicians in
real-world VA clinical settings are urgently needed to generate actionable evidence to support clinical
guidelines for the care of this high-risk population.
Specific Aims: Aim 1: Convene SMEs (clinicians, researchers, and VA operational partners) who will assist
the research team in developing a pragmatic implementation-effectiveness trial protocol to compare two
integrated interdisciplinary approaches (including a medical prescriber) for the simultaneous treatment of
Veterans with co-occurring chronic pain and PTSD prescribed opioids. Aim 2: Convene Veterans with lived
experience to review components of the draft protocol to ensure inclusivity, acceptability, and feasibility.
Methodology: For Aim 1, through individual interviews and group meetings, SMEs will use extant published,
unpublished, VA EHR data (generated as part of this study), and their own experience to provide input in
iteratively developing and refining a pragmatic implementation-effectiveness trial protocol to compare a more
traditional trauma-informed CBT-based intervention to a trauma-informed complementary and integrative
health intervention for Veterans with co-occurring chronic pain and PTSD who may be prescribed opioids. For
Aim 2, we will convene a Veteran engagement panel (VEP) including a diverse and inclusive group of Veterans
with lived experience of pain, PTSD, and prescription opioid use. The VEP will provide feedback on the draft
trial protocol to ensure trial interventions and components will be acceptable and feasible for Veterans and
responsive to their needs and preferences for care. Incorporating SME and VEP input from Aims 1 and 2, the
research team will finalize the trial protocol, forming the basis of a subsequent MERIT Review proposal.
Next Steps/Implementation: This study will result in the first-ever multi-site pragmatic implementation-
effectiveness clinical trial protocol to comparing two integrated interdisciplinary interventions for the care of
Veterans with co-occurring chronic pain and PTSD prescribed opioids. We have included VA operations
partners (e.g., Office of Pain Management, National Center for PTSD, Office of Patient-Centered Care) as
study stakeholders. Operations partners will be invited to partner in the next step which involves submitting a
VA MERIT Review proposal to seek funding for a multi-site pragmatic implementation-effectiveness trial.

Public health relevance
Chronic pain and posttraumatic stress disorder (PTSD) are prevalent co-occurring conditions in Veterans, and these conditions are associated with poorer functioning and health outcomes. When these conditions occur together, they can be challenging to treat, especially when Veterans are prescribed opioids. To date, there have been no large, controlled trials comparing interventions to treat co-occurring pain and PTSD in Veterans prescribed opioids. Thus, we have no evidence to guide VA clinicians in providing best practice care for this relatively large at-risk population of Veterans. Based on input from clinicians, researchers, VA leaders, Veterans with lived experience, as well as information from the care of these patients in VA from the electronic health record, this study will develop the first clinical trial protocol to compare two novel integrated interventions for the care of Veterans with co-occurring chronic pain and PTSD who may be prescribed opioids.